Binding of Epstein Barr Virus EBNA2 Unifies Multiple Sclerosis Genetic Mechanisms

Multiple sclerosis (MS) is a devastating disease of the central nervous system that affects over 2.3 million
people worldwide. Current therapies for MS are at best only partially effective, and there is no cure. Improved
understanding of MS disease mechanisms would lead to better diagnosis, treatment, and prevention. MS is
caused by both genetic and environmental risk factors. Epstein-Barr virus (EBV) is the most consistently
replicated environmental factor. Mounting evidence indicates that EBV-infected B cells, and their downstream
immunological effects, are key drivers of MS disease processes. Recent work by our group and others implicates
the EBV-encoded EBNA2 gene regulatory protein in mechanisms at almost half of the established MS genetic
risk loci. In this proposal, we will test the hypothesis that EBNA2-driven allele-dependent alterations to human
gene expression lead to distinct B and T cell phenotypes directly contributing to disease processes in MS.
Aim 1. Quantification of EBV-specific human gene expression in multiple MS patient
demographics. We will expand our cohort to include males and females of European, African, and Asian
ancestries. We will measure MS- and EBV-specific human gene expression in these cohorts.
Aim 2. Global discovery of EBV- and MS genotype-dependent gene regulatory mechanisms. We
will use Massively Parallel Reporter Assays (MPRAs) to systematically identify EBV- and risk allele-dependent
gene expression at all MS risk variants in primary B cells with and without EBV infection. We will identify human
transcriptional regulators acting with EBNA2, EBNA3C, and/or EBNA-LP at these loci and confirm their allele-
dependent actions in MS-derived B cells using cutting-edge functional genomics technologies. We will validate
these EBV- and genotype-dependent gene regulatory mechanisms using CRISPR-based genome editing of
patient-derived primary B cells at CD37, CD58, ZMIZ1, and other MS risk loci.
Aim 3. Discovery of allelic EBV-based mechanisms altering cellular behavior in MS. We will gauge
the necessity and sufficiency of EBV and specific MS variants (e.g: CD37, CD58, ZMIZ1) on B cell function using
the CRISPR-edited B cells. We will measure impact on B cell receptor signaling, cytokine production,
proliferation, and apoptosis. We will use an inducible pluripotent stem cell-derived blood brain barrier (BBB)
endothelium model to measure the impact of EBV and MS risk alleles on B cell - BBB interactions.
The concept that disease processes might be influenced by virus-controlled, allelic regulatory protein
complexes is highly innovative and has never before been demonstrated. Our work for the first time provides
mechanistic insight into the established role of EBV in MS through a unified gene by environment model.
Comprehensive cataloging, dissection, and understanding of the downstream effects of genetic mechanisms
impacted by EBV will be significant because it will provide strong rationale to develop therapies that interfere
with these mechanisms, or even vaccines that prevent EBV infection to cure MS and other EBV-related diseases.

Public health relevance
Project Narrative The proposed research is relevant to human health because it will discover specific molecular events that contribute to multiple sclerosis, leading to better diagnostics, treatments, and eventually cures. This project is relevant to the NIH’s mission, and the mission of NINDS in particular, because it will provide fundamental insights into the role of the Epstein-Barr virus and human genetics in the etiology of multiple sclerosis.